Comprehensive Anesthesia Research Training

PROJECT SUMMARY This application is for an Administrative Supplement for Curriculum or Training Activities to Enhance Wellness and Resiliency in the Training Environment. The goal of our T32 training grant program, Comprehensive Anesthesia Research Training, is to provide in-depth research training to anesthesiologists and allied scientists who are committed to pursuing basic, translational and/or clinical research on topics in anesthesiology, critical care medicine, pain medicine and the perioperative sciences. There is a need to develop a wellness curriculum for trainees in our program, as physician-scientists face unique challenges navigating the research training pathway, including balancing large research commitments with high intensity clinical work and expectations to participate in mentoring, education, and service. This Administrative Supplement will be used to develop a wellness curriculum that will provide formalized mechanisms for trainee peer support and community building, expanded trainee career mentorship, and opportunities for trainees and faculty mentors to learn about well- being concepts, research, and resources. The specific training activities include: (1) a Wellness and Resilience Support Group of current and past trainees and junior research faculty who will participate in wellness workshops and community building activities, (2) expanded career development mentorship and planning to address unique issues encountered by physician-scientists in training (e.g., effectively balancing clinical work and research), (3) an Annual Wellness Research seminar and opportunities for trainees to interact with the Visiting Professor, and (4) the development of a map of well-being resources within the department, at UCSF, and externally (e.g., through OITE) that are available to research trainees and faculty mentors. We anticipate that the activities and resources will be initiated and implemented using this Administrative Supplement, and then will be sustained in the T32 program and the larger departmental Pathway to Scientific Independence research training program. The effectiveness of the wellness program will be assessed using (1) surveys of trainees at the beginning and end of the year of supplemental support, and over the following 3 years, focused on parameters of wellness and research success (publication rates and extramural funding), (2) trainee attendance at wellness-oriented workshops and community building activities, (3) trainee and faculty attendance at wellness seminars, and (4) trainee evaluations of the program activities. The outcomes will be disseminated to the Department of Anesthesia through the Anesthesia Research Newsletter and externally through publications on the effectiveness of the program in peer-reviewed journals. The T32 Executive Committee and Department Chair will also participate in the dissemination of outcomes through institutional, local, and national presentations. This new wellness curriculum program will equip anesthesiologist research trainees with the knowledge and support to navigate a challenging research training pathway and will enhance their ability to develop into successful biomedical researchers.

Public health relevance
PROJECT NARRATIVE This T32 training grant program provides the next generation of anesthesiologists and allied scientists with rigorous training in research so that they can bring more scientific discoveries to patients. This administrative supplement program will be used to incorporate activities and resources to promote the wellness and resiliency of trainees. Features of the program will be the development of a Wellness and Resilience Support Group of current and past trainees and junior research faculty, expanded career development mentorship and planning to address unique issues encountered by physician-scientists in training (e.g., effectively balancing clinical work and research), opportunities for trainees to interact with the visiting professor at the department’s Annual Wellness Research seminar, and the development of a map of well-being resources within the department, at UCSF, and externally (e.g., through OITE) that are available to research trainees and faculty mentors.